Rigorous Assessment of P. vivax Relapses and Primaquine Efficacy for Radical Cure

Plasmodium vivax threatens half of the world’s population. While on-going malaria elimination efforts are
successfully reducing the burden of falciparum malaria worldwide, the situation is much less promising for P.
vivax. In particular, the unique ability of P. vivax parasites to remain dormant in the liver and cause relapse
infections weeks or months later greatly complicates malaria elimination campaigns. Here we propose to conduct
a tightly-controlled field study in Cambodia, specifically designed to support and empower state-of-the-art
genomic analyses, to determine the frequency of relapse and the factors associated with hypnozoite reactivation,
as well as to rigorously evaluate the efficacy of different doses of primaquine for radical cure treatment. Our
studies will provide a unique perspective on P. vivax relapse and will contribute to better understand how to
successfully eliminate this understudied parasite.

Public health relevance
The reactivation of Plasmodium vivax dormant parasites is one of the major challenges to current malaria elimination efforts. We propose to implement a tightly-controlled field study in Cambodia, specifically designed to empower state-of-the-art genomic analyses, to rigorously study P. vivax relapses and the efficacy of primaquine radical cure. Our studies will provide a unique perspective on the mechanisms regulating these dormant parasites and will provide immediately-relevant clinical information to better eliminate this important human parasite.